21st International Conference of the Society for Integrative Oncology

PROJECT SUMMARY/ABSTRACT
The Society for Integrative Oncology (SIO) 21st International Conference, "Full Circle
Translational Integrative Oncology: Bedside to Bench and Back - The transformative
power of clinical observation to ignite scientific discovery and optimize patient outcomes,”
aims to encourage scientific and clinical collaboration across global and inter-professional
boundaries to advance knowledge, therapies, and care delivery that will ultimately improve the
quality of life and clinical outcomes for individuals and families living with cancer around the world.
This year’s conference – SIO2024 – will focus on disseminating important and practical findings
from integrative oncology research that have the potential to transform cancer care.
This three-day meeting will be held in Orange County, CA from October 25 to October 27, 2024,
and hosted by City of Hope (COH). SIO2024 will feature three keynote lectures that highlight the
conference theme: 1) an overview of the newest immune-oncology approaches with a focus on
CAR T-cell therapy; 2) natural product drug discovery for anticancer therapy, and 3) the
intersection of spirituality and integrative oncology. The conference will include three moderated
plenary panels that focus on the current state of the science for: 1) natural products and
immunotherapy; 2) nutrition and metabolomics; and 3) applying artificial intelligence/machine
learning to integrative oncology.
The conference will also include seven educational sessions and workshops, five concurrent oral
abstract sessions, three lunch session focusing on nutrition, mind-body medicine, and diversity &
equity in integrative oncology, as well as patient advocacy and trainee/new investigator tracks We
will solicit at least 75 oral and up to 150 poster presentations of original research from members
of the national and international research community. The conference’s specific aims are to: 1)
create an international forum in which of researchers, clinicians, trainees, and patient
advocates with an emphasis on diversity including women and minorities can learn about and
discuss the current evidence for the interplay of integrative oncology research and clinical
application to enhance their understanding of the advantages and challenges of this field; 2)
foster critical dialogue and collaboration opportunities among researchers, health
professionals, and patient advocates to strengthen the translational potential and clinical
relevance of future research in integrative oncology; and 3) support the training of early
investigators and patient advocates to interpret, disseminate, and develop evidence-based
integrative oncology research. Ultimately, we hope that SIO2024 will improve the outcomes of
cancer care in patient communities around the world.

Public health relevance
Project Narrative The Society for Integrative Oncology (SIO) 21st International Conference, " Full Circle Translational Integrative Oncology: Bedside to Bench and Back - The transformative power of clinical observation to ignite scientific discovery and optimize patient outcomes,” aims to encourage scientific and clinical collaboration across global boundaries to advance the knowledge, therapies, and care delivery of integrative oncology to improve quality of life and clinical outcomes. This conference will also continue to emphasize the training of diverse early career investigators and patient advocates in creating, interpreting, and disseminating evidence- based integrative oncology research, and increasing its potential clinical utility. Ultimately, it is our hope that this conference will provide renewed knowledge of the art and science of integrative oncology to improve patient care outcomes by integrative oncologists and other health care professionals working with individuals and their families living with cancer worldwide.